Air pollution and cardiopulmonary health: Susceptibility by HIV infection status

PROJECT SUMMARY/ABSTRACT
Air pollution is a leading cause of mortality globally, contributing to nearly 1 in 10 deaths and 147 million years
of healthy life lost annually. Fine particulate matter (PM2.5) is a key component of air pollution; it is highly
regulated and is the component of the air pollution mixture most consistently and strongly associated with
cardiovascular and respiratory mortality. While exposure to PM2.5 is associated with adverse cardiopulmonary
effects in the general population, associations are even stronger among susceptible populations, including
those with preexisting cardiovascular or respiratory disease. Identifying subgroups experiencing differential
PM2.5-related health effects is key to informing policy and intervention strategies to protect our most vulnerable
populations. There are 38 million people with human immunodeficiency virus (HIV) infection worldwide and 1.7
million new HIV infections each year. Improvements in antiretroviral therapy have led to longer life
expectancies for people with HIV, but other health risks have arisen from chronic infection. Cardiopulmonary
disease is a leading cause of morbidity and mortality among people with HIV due to long-term inflammation
from infection as well as some antiretroviral therapy. Further, people with HIV may be at higher risk for adverse
cardiopulmonary health effects from traditional risk factors as compared to the general population. The majority
of the world's population is exposed to PM2.5 levels higher than the World Health Organization's (WHO)
guideline for healthy air, but it is unknown if people with HIV are more susceptible to cardiopulmonary disease
resulting from this exposure than the general population. The specific aims of this project are to 1) examine
HIV infection as a potential modifier of the association between PM2.5 and systolic blood pressure, and 2)
examine HIV infection as a potential modifier of the association between PM2.5 and percent predicted forced
expiratory volume in the first second (FEV1). This study will take place in Matlosana, South Africa, a peri-urban
district experiencing a confluence of high HIV prevalence and ambient PM2.5 levels regularly exceeding the
WHO's 24-hour guideline of 25 µg/m3. With 7.5 million people with HIV, South Africa has the highest absolute
burden of HIV in the world and an increasing burden of cardiovascular disease and chronic obstructive
pulmonary disease (COPD). South Africa also has the second highest age-standardized death rate attributable
to air pollution among all sub-Saharan African countries. The career development plan includes didactic and
experiential training in cardiopulmonary physiology and air pollution exposure assessment, which will help the
candidate implement the current project with fidelity and achieve her long-term goals of reducing air pollution
exposure and prevent cardiopulmonary disease among people with HIV. She will have the support of a
mentoring team and Advisory Committee with extensive experience in air pollution epidemiology and
measurement, HIV clinical research, and cardiopulmonary physiology and health outcomes.

Public health relevance
NARRATIVE Identifying and quantifying risk of air pollution exposure with adverse health outcomes among susceptible populations is an important strategy for the development of prevention and intervention strategies, estimating global burden of disease, and informing policy. Worldwide, there are 38 million people with HIV, and while advances in antiretroviral therapy have drastically increased life expectancies, people with HIV are at greater risk thank HIV seronegative peers for cardiovascular disease and pulmonary comorbidities, including chronic obstructive pulmonary disease (CODP). The proposed work will be conducted in South Africa, which has the greatest number of people with HIV in the world, and will examine whether people with HIV have increased susceptibility to the adverse cardiopulmonary health effects from air pollution exposure.